A Behavioral and Neural Investigation of Young Children's Attention and Comprehension on Interactive Video Viewing Platforms

PROJECT SUMMARY / ABSTRACT
As children’s media consumption shifts to platforms like YouTube, young children are increasingly exposed to
rapid video-switching, a feature that may disrupt attention and learning. This developmental cognitive
neuroscience study will investigate how video-switching affects young children’s attention and comprehension.
Using a within-subject experimental design, we will manipulate two viewing conditions—switching and non-
switching—on a custom-built platform that simulates YouTube. Three-year-old children will watch educational
videos while their sustained and selective attention are measured at both neural and behavioral levels using
EEG and eye-tracking. After viewing, we will assess children’s comprehension. Additionally, we will analyze
switching behaviors in both naturalistic and controlled settings to test potential associations. Our study
addresses a significant gap in understanding how media design features, specifically video-switching, impact
early cognitive development. Given the urgent need to evaluate the effects of these features on young
children, our research will provide critical evidence to inform guidelines for healthy media use in early
childhood. Specifically, we will address three aims: 1) assess the impact of video-switching on attention, 2)
examine its effects on comprehension, and 3) investigates associations between switching behaviors in
naturalistic and experimental settings.

Public health relevance
PROJECT NARRATIVE As children’s media consumption increasingly shifts to platforms like YouTube, there are growing public health concerns about how rapid video-switching enabled by such platforms may affect young children’s cognitive development, particularly their attention and learning. This study will use EEG and eye-tracking methods to examine the impact of video-switching on 3-year-olds’ attention and comprehension, providing important knowledge about how media environments influence early development at both behavioral and neural levels. Findings from this research will contribute to evidence-based guidelines that promote healthy media use in early childhood, addressing a critical public health issue.